N6-methyladenosine in Candida white-opaque switching and oral infection

Project Summary / Abstract
Candida albicans white-opaque switching is an epigenetic process that regulates its mating ability, virulence,
and colonization of different niches in the human host. One of these niches is the oral cavity, where Candida
species can cause painful infections called oropharyngeal candidiasis (OPC). While there are known
environmental cues and transcriptional regulators that control the white-opaque switch, a mechanistic
understanding of how specific environments trigger switching to one state or another and how this contributes
to colonization and infection is lacking. This proposal will investigate how the RNA modification N6-
methyladenosine (m6A) acts to mediate white-opaque switching and mating in C. albicans. Preliminary studies
from my collaborator and I have found that cells lacking IME4, the m6A methyltransferase, are impaired in
temperature-induced opaque to white switching and have an increased mating efficiency. As someone with a
background in Candida white-opaque switching and m6A biology, I am uniquely qualified to investigate the
hypothesis that m6A regulation mediates environmental signals that induce phenotypic changes
that mediate infection by C. albicans. Aim 1 is to identify targets of m6A modification in white-opaque
switching by using eCLIP to map single nucleotide sites of m6A modification and binding sites of MRB1, the m6A
reader, as well as gene expression analysis in wild-type and ime4 mutant white and opaque cells. Aim 2 will
determine how the environment regulates m6A in switching and filamentation by generating gene expression
and metabolomic profiles of cells under environmental conditions such as high temperature or CO2 that induce
white-opaque switching or filamentation. Aim 3 will investigate the role of m6A in oral colonization of C. albicans
by using cell culture and mouse models of OPC. White-opaque switching regulates oral colonization, and we
hypothesize that IME4 plays a role in this process. In this aim, I will also study how radiation affects Candida
cells lacking IME4 and how it affects colonization of the murine oral niche. In aim 4 I will investigate the function
of m6A in interactions with the oral microbiome. Many of the m6A modified genes I have identified are involved
in interspecies interactions, suggesting that IME4 and m6A regulate these interactions within the host. This
research plan will be the first to combine the fields of epitranscriptomics and Candida biology to study how m6A
contributes to the lifestyle and pathogenicity of a clinically relevant fungal species, with the potential to pave the
way for new anti-fungal drug treatments for OPC. I have proposed a comprehensive training program for the
K99 phase of this proposal including acquisition of new skills in bioinformatics, metabolomics, animal models
of oral infection, microbiome analyses, guidance from an advisory committee of prominent mentors and
collaborators, and development of key professional and leadership skills. Collectively, this plan will facilitate my
transition to independence during the R00 phase and prepare me for a career as an independent researcher.

Public health relevance
Project Narrative Oropharyngeal candidiasis is a major clinical issue for a diverse group of people, including cancer patients. We have found that the RNA modification m6A regulates white-opaque switching, an epigenetic phenotypic switch that controls aspects of mating, filamentation, biofilm formation, and ability to colonize and infect the human host. This proposal aims to investigate the mechanisms of m6A in regulation of the C. albicans white-opaque switch, environmental responses, metabolism, colonization of the oral niche, exposure to radiation treatment, and interactions with other oral microbes.